Mechanism of Immune Dysfunction and Morbid Outcomes in Response to Shock/Sepsis

Summary/Abstract:
At last count, sepsis was reported to be the leading cause of death in U.S hospital intensive care units (ICU);
accounting for ~1 in 5 deaths world-wide; its incidence is anticipated to rise as the populations in developed
countries age; and it was the consensus cause of death assigned to those dying from COVID-19 infection.
Most frustrating, is that while we continue to optimize the supportive care for these critically ill patients, we
have yet to see a novel molecular etiology-based therapy make a sustained impact on overall septic
morbidity/ mortality. Excitingly, while working for years on defining numerous defects of components of both
adaptive and innate immune responsiveness induced by shock and/or sepsis, we have uncovered novel
role(s) for a number of the B7-family of cell-associated co-inhibitory receptors, Programmed Cell Death
Receptor-1 [PD-1], B-/T Lymphocyte Attenuator [BTLA], recently, V-domain Immunoglobulin Suppressor of T
cell Activation [VISTA, a.k.a., B7-H5, PD-1H] and their respective cell surface ligands; popularly referred to
as checkpoint proteins. In this competitive renewal of our MIRA program, we propose to continue to push
forward the 3 project areas we brought together previously under the over-arching concept that by
understanding the mechanism(s) of injury/shock and/or sepsis that serve to predispose animals
(experimentally) or critically ill/injured patients to develop morbid outcomes, we can elucidate not
only novel prognostic markers of patient's course but uncover unique therapeutic targets for their
treatment. In the 1st Project area, we will determine how the select expression of PD-1, BTLA or VISTA, on
myeloid as opposed to lymphoid cells alters the development of morbid events associated with sepsis; then,
how the expression of ligands for these co-inhibitory molecules, on leukocytes and/or endothelial/epithelial
cells, contribute to the onset of septic liver, intestine and/or kidney dysfunction. In our 2nd Project area, we
will utilize a novel murine model of indirect-acute lung injury (iALI)(dual insults of hemorrhage shock followed
by cecal ligation & puncture [CLP]) to ask how checkpoint protein expression not only effect the patho-
mechanisms driving the development of iALI, but how are these co-inhibitors alter cell `priming'/'innate
immune memory'/function by following pulmonary immune/non-immune cell transcriptomic/ epigenomic
fate/programing. Finally, (3rd Project) since the neonate possesses a unique/naïve immune system and is
more susceptible to morbid response in the face of infectious challenge; we ask how the expression of
members of the B-7 family of proteins and/or their ligands not only have a comparative impact on the
response to septic insult, but how this alters their microbiota and epigenetic makeup/immune function as
survivors mature? To do this we will interrogate these 3 cogent models of sepsis, shock/sepsis and/or
neonatal sepsis, by applying a combination genetic/Cre-Lox mouse models, adoptive transfer, single cell
RNA-seq/ATACseq, 16S microbiota RNA-seq and bisulfite/pyrosequencing to examine these hypotheses
along with select observational clinical studies in the critical ill patient population.

Public health relevance
Project Narrative Despite the use of state-of-the-art supportive care and a variety of novel anti-inflammatory agents in critically ill/injured patients, multiple organ failure continues to be a major cause of morbidity/mortality in the surgical intensive care unit. This study is designed to determine if a family of novel checkpoint proteins, expressed on immune and non-immune cells, can be used to block the development of organ injury in the critically ill patient.